AFC Hazardous Materials Worker Training

AFC PROGRAM SUMMARY
With this application, the Alabama Fire College (AFC) Workplace Safety Training Program (WST) proposes to
continue delivering model NIEHS-funded training to two worker populations – members and employees of
Native American tribes nationwide and Public Safety Personnel within the southeastern U.S. Both target
populations face significant health and safety risks due to potential exposure to hazards during (1) emergency
response to uncontrolled releases of hazardous materials (hazmats), (2) emergency response to disasters
caused by accidental hazmat releases caused by severe weather events or man-made hostile events, and (3)
work assessing and remediating uncontrolled hazardous waste dumps. They also face highly dangerous illicit
“laboratories” producing drugs, weapons of mass destruction (WMD) or other harmful agents. All these
emergencies represent significant hazards to the health and safety of the responders and the communities
they serve. The 574 federally recognized Native American tribes include 2.4 million members living in the
contiguous 48 states and Alaska on over 56 million acres of land through which run hundreds of thousands
of miles of rivers, roads, and railroad rights-of-way, making transportation accidents a significant threat.
Additionally, according to the Bureau of Labor Statistics, there are 76,420 firefighters, 54,400 emergency
medical technicians and paramedics and 150,590 police and sheriff’s patrol officers in the southeastern
states where the program has been most active: Alabama, Georgia, Florida, Mississippi, Louisiana,
Tennessee, North Carolina and South Carolina. AFC will be joined by Native American Fish and Wildlife
Society to promote the proposed training to tribal emergency response personnel. AFC/WST will use the
growing network of contacts developed over its 36-year history (as WST) as well as the broader AFC’s
leadership in North American Fire Training Directors and other networks of training providers to carry training
to public sector responders. This training will include existing courses in topics such as hazardous materials
emergency response (Awareness, Operations, Technician, Incident Commander levels), incident command
systems, air monitoring, mass casualty incident triage, confined space rescue, illicit laboratory response,
hostile event response, and responder safety during natural and man-made disasters. Hazardous waste
worker initial and refresher training will be included the training plan. The training will be delivered directly by
AFC instructors and through secondary training by trainees who take the training back to their tribes and local
agencies. AFC instructors are projected to directly train over 2,100 Native American responders and over
3,100 public sector responders in both programs. In addition, peer trainers will use AFC materials to train an
additional 1,875 of their peers. In total for the five years, AFC projects to conduct over 395 classes to over
7,075 trainees in 112,900 contact hours through direct and secondary training.

Public health relevance
PROJECT NARRATIVE The Workplace Safety Training Program of the Alabama Fire College proposes to provide training to Native American and public sector emergency response personnel that will prepare them to safely respond to hazardous materials releases resulting from transportation and industrial incidents, natural and manmade disasters, hostile events like terrorist attacks or active shooters and illicit drug use and manufacture. Both target populations are charged with responding to such emergencies by Environmental Protection Agency, Occupational Safety and Health Administration, Department of Transportation, and Department of Homeland Security regulations, but do not have sufficient budgets and resources to provide such training. The proposed project will bring critical training to over 7,000 responders in both populations that will help them to better protect themselves and the communities they serve.